Vanderbilt Chemical Biology Interface Training Program

PROGRAM ABSTRACT
This proposal requests support for a Vanderbilt Chemistry-Biology Interface (V-CBI) Training Program at
Vanderbilt University. Forty faculty preceptors from over eight Ph.D. granting departments and programs in the
Colleges of Arts and Sciences, Engineering, School of Medicine Basic Sciences, and Vanderbilt University
Medical Center will serve as mentors for the Program. Significant training and education in biology will be
provided to students receiving in-depth training in synthetic/mechanistic and analytical chemistry and significant
training and education in the chemistry will be provided to students receiving in-depth training in the biological
sciences. Highlights of the training program include a common chemical biology 15 week course, elective
courses for cross education, a course in experimental design and research reproducibility, student organized
research and professional development seminars, a seminar series in chemical biology, an annual research
symposium, participation in an annual career development conference and a unique experience in laboratory
experimental design and technical training for application in an undergraduate research laboratory. Students will
receive in-depth education and training in a core discipline and cross training in complementary fields to allow
them to work effectively in multidisciplinary research environment. Support for ten trainees is requested. Trainees
will obtain Ph.D. degrees working with preceptors in such the Departments of Biochemistry (11 preceptors),
Chemistry (13), Cell and Developmental Biology (2), Pathology and Microbiology (4), Pharmacology (3) and
Molecular Physiology & Biophysics, Anesthesiology and Pharmacology (3), Chemical and Biomolecular
Engineering (2), Pediatrics (2), Radiology and Radiological Science (1-2 each), among others.

Public health relevance
NARRATIVE The trainees participating in the CBI training program are engaged in a number of NIH-supported projects that employ techniques, understanding and tools of chemistry to study a variety of biomedical problems with relevance to the study of human biology, health and therapeutic agent development.